Case Western Reserve University Center of the NICHD MFMU

Obstetric practices and treatments are steeped in tradition, often introduced without rigorous evaluation
based on “expert” opinion. Practices are often influenced by the media with societal acceptance then entering
common practice without an assessment for risk or benefit. Because obstetrics often impacts two patients it is
important to understand the potential consequences for both individuals when a new intervention, medication,
or device is introduced into clinical practice. A treatment may benefit the mother but harm the fetus or inversely
benefit the fetus but harm the mother. These adverse events have both social and financial implications for both
the family and society. In addition, new therapeutic interventions can be associated with increased healthcare
expenditures. These social and financial burdens need to be determined to help mold health care policy and
practice.
Since its inception, the Eunice Kennedy Shriver NICHD Maternal-Fetal Medicine Units (MFMU)
research network has conducted clinical trials and observational studies that have provided new knowledge to
our understanding of pregnancy especially in the area of prematurity. Past studies have demonstrated the benefit
of 17-OH progesterone caproate to reduce the risk of preterm delivery and antibiotics to prolonged pregnancy
after premature preterm rupture of the membranes, among other effective interventions. Other studies have put
an end to expensive and ineffective interventions, such as fetal pulse oximetry and fetal heart rate ST segment
analysis, both of which failed to change delivery outcomes. MFMU network studies have played a significant
role in providing evidence for and against numerous practices over the past 24 years.
In this application, we demonstrate that the investigators in the Department of Reproductive Biology at Case
Western Reserve University (CASE) have the ability to conduct collaborative research and have successfully
participated in the MFMU research network and are qualified to continue as a study center. Our investigators
have a diverse background in clinical trials and multi-center studies providing a depth of experience for future
as well as on-going studies. Our center has performed well in both recruitment and data quality while
maintaining high rates of participant retention. The CASE community (participating institutions and medical
school) has been and continues to be highly supportive of the CASE-MFMU study center and our investigators.
The CASE study center has provided leadership and participated in the administrative operations that lead to the
success of the entire MFMU network. Our use of administrative processes to improve recruitment and hold
down costs has been innovative. CASE provides a strong administrative and research infrastructure such as the
CASE-Clinical & Translational Science Collaborative to support our study center operations. The CASE study
center team is ideally positioned to provide leadership with exceptional performance in the coming MFMU
Network cycle.

Public health relevance
The Case Western Reserve University Study Center team proposes to participate in the Eunice Kennedy Shriver NICHD multicenter Maternal-Fetal Medicine Units (MFMU) research network as a collaborative member with a focus toward reducing preterm birth and reducing maternal and neonatal morbidities. We will provide our leadership and resources to contribute toward the success of network operations.